Pathogenesis of myalgia and fatigue after SARS-CoV-2 infection

PROJECT SUMMARY
As the COVID-19 pandemic continues, managing post COVID-19 long-haul symptoms have become the next
level challenge. Persistent skeletal muscle aches (myalgia) and fatigue are among the most common
symptoms reported by COVID-19 long haulers who have symptoms beyond 20 weeks. The myalgia associated
with COVID-19 often responds poorly to pain medications. The long-COVID symptoms, especially myalgia,
fatigue, dyspnea, and brain fog, significantly affect the quality of life and employment status of COVID-19 long
haulers. Although myalgia and fatigue are common during acute respiratory viral infection, the muscle
symptoms caused by SARS-CoV-2 often last much longer than other respiratory viral infections including
influenza. The pathogenic mechanisms underlying the development and persistence of myalgia and fatigue
associated with COVID-19, however, is largely unknown, which makes the treatment difficult. We thus propose
this R21 study to explore the mechanisms. There are four potential mechanisms, including direct viral invasion
to skeletal muscle, ischemic muscle injury from microthrombi and cardiopulmonary dysfunction, immune-
mediated muscle damage caused by an exuberant systemic inflammatory response, and altered muscle
energy homeostasis. We propose to address these mechanisms by conducting an exploratory longitudinal
study to characterize the skeletal muscle response to respiratory SARS-CoV-2 infection to determine how
skeletal muscle is affected at the histopathological level and transcriptional level during and after acute
infection, and whether the muscle responses to SARS-CoV-2 and influenza A (IAV) viral infections are
different. By using muscle tissues collected from SARS-CoV-2-infected golden hamsters, one of the best small
animal models for COVID-19, our preliminary study found no detectable SARS-CoV-2 nucleocapsid protein or
inflammation to suggest direct viral invasion to muscle. There were no microthrombi either. These findings lead
to our central hypothesis that myalgia and fatigue associated with COVID-19 are likely caused by altered
muscle energy metabolism due to a systemic inflammatory response and hypoxia during acute SARS-CoV-2
infection, followed by a prolonged recovery course. This hypothesis will be addressed by two specific aims.
Aim 1 will identify muscle histopathological changes at different stages after SARS-CoV-2 infection and
compare with IAV infection. Aim 2 will characterize the muscle transcriptional response to SARS-CoV-2
infection and the dynamic transcriptional changes with time. We will also compare SARS-CoV-2 infection with
IAV infection to address whether the recovery of the initial skeletal muscle response to SARS-CoV-2 infection
is slower. Our study will likely identify histopathological features and transcriptional signatures that may
underlie myalgia and fatigue associated with COVID-19. The mechanisms uncovered will help guide therapies.

Public health relevance
PROJECT NARRATIVE As the COVID-19 pandemic continues, managing the long-COVID symptoms after the recovery from acute viral infection have become the next level challenge. Muscle aches and fatigue are not only the debilitating symptoms in patients who suffer from acute COVID-19, but also the major symptoms reported by patients who suffer from long-COVID symptoms; however, the pathogenic mechanisms are largely unknown. We will explore the mechanisms by using the hamster model of COVID-19 to study the skeletal muscle response (changes in muscle pathology and gene expression) to SARS-CoV-2 infection at acute, subacute, and chronic stages.